Precision whole-body imaging of pancreatic cancer senescence with ImmunoPET

Project Summary
Pancreatic cancer is the fourth most prevalent cancer death in both sexes with less than 10% overall
survival over 5 years. In patients diagnosed with pancreatic cancer, first-line chemotherapy with
gemcitabine often requires second-line therapies such as FOLFIRNOX (folinic acid, fluorouracil,
irinotecan, and oxaliplatin), with median survival ranging from 6 to 26 months. While the survival of
pancreatic cancer has not dramatically progressed with new therapeutic combinations, most of the
chemotherapeutic regimens used for pancreatic cancer induce senescence. Cells can undergo
senescence through replication, oncogene induction, as well as targeted drug therapy. Senescent cells
have been implicated in tumorigenesis via pro inflammatory factors secreted by senescent cells and
modification of the tumor microenvironment. It is unknown to what degree senescence occurs in patient
tumors and how the senescence-associated secretory phenotype (SASP) changes with therapy.
Immunotherapy has revolutionized many cancer treatments with precision medicine and targeted
antibody therapies, but these treatments have lent only a modest increase in survival time to pancreatic
cancer patients. Newer methods to target pancreatic cancer and identify senescent pancreatic cancer
during treatment are needed. Recent work from the Scott Lowe Lab demonstrated that pancreatic
cancer senescence could be induced with the combination of trametinib and palbocicilib, leading to the
release of cytokines that remodel the tumor microenvironment. The current gold standard method for
identification of senescence cells has focused on a small molecule for lysosomal trafficking with beta-
galactosidase activity. Specific markers for SASP using antibody-based agents are needed. Previously
elevated SASP markers include VEGF, P-selectin, uPAR, CCl2 and CCL5, and Interleukins 1, 6, and
12. This fellowship proposes to use clinically available antibodies against known SASP markers to
visualize and quantify SASP activity in vivo with ImmunoPET. By using an antibody-based approach,
senescent cells can be selectively targeted with greater specificity than small molecules. This is
extremely important work, allowing for the in vivo quantification of SASP under numerous models and
therapeutic combinations and identifying how a senescent population could lead to resistance and
metastasis. Future work with ImmunoPET tracers specific to senescent tissue could include conjugation
with senolytic drugs as well as stand-alone antibody endoradiotherapy.

Public health relevance
Project Narrative Pancreatic cancer has a dismal 5% five-year overall survival rate, and the most effective therapies to date include chemotherapies like gemcitabine. Chemotherapy is known to induce senescence, a type of cell arrest that leads to inflammation and is implicated in metastatic disease and therapy resistance, marking an urgent need for noninvasive imaging agents for senescence. PET imaging with antibodies will provide specific detection and quantification of senescent tissue with the possibility to chaperone senolytic drugs or radiation for improved pancreatic cancer therapy.